Cognitive Behavioral Immersion: A Randomized Control Trial of Peer-Based Coaching in the Metaverse

PROJECT SUMMARY/ABSTRACT
Depression and anxiety rank among the largest public health burdens worldwide. While effective first-line
treatments like cognitive behavioral therapy have been shown to be effective, there are numerous barriers to
accessing this kind of clinician delivered care (e.g., cost, provider availability, stigma). There is a critical need for
effective and affordable interventions that can scale and provide mental health support for the millions of
individuals around the world with depression and anxiety who are currently underserved. The Phase I project
focused on the development and feasibility of Cognitive Behavioral Immersion™ (CBI), defined as the delivery
of cognitive behavioral skills training by peer-based coaches in the metaverse. CBI has the potential to deliver
effective, affordable, and scalable support to those with depression and anxiety. While there is initial evidence
supporting the feasibility of CBI for depression and anxiety, a direct comparison of this modality against its
absence or another effective treatment has yet to be conducted and its relative efficacy is unknown. In addition,
it is unknown whether immersive virtual reality confers benefits in cognitive behavioral skill training above and
beyond flat screens accessing the same content. The proposed Phase II project aims to evaluate the efficacy of
an immersive CBI program accessed via VR headsets (CBI-VR) as compared to a treatment-as-usual (TAU)
control and a non-immersive CBI condition accessed via flat screens (CBI-flat screen) in a randomized controlled
trial. Upon completion of this aim, the proposed project will have further developed the CBI platform as well as
tested the efficacy of this program. This will help with eventual partnerships with larger payers and employee
assistance programs. The proposed project will also enhance the value proposition for both direct to consumer
and business to business phases.

Public health relevance
PROJECT NARRATIVE Cognitive Behavioral Immersion™ (CBI), defined as the delivery of cognitive behavioral skills training groups by lay coaches in the metaverse, has the potential to provide effective, affordable, and scalable support to those with depression and anxiety. The proposed randomized control trial is designed to evaluate the efficacy of CBI accessed via VR headsets (CBI-VR) to a treatment-as-usual (TAU) control and a non-immersive CBI condition accessed via flat screens (CBI-flat screen). If proven to be efficacious, the CBI platform could be marketed as an accessible, affordable, and scalable mental health program with utility to help individuals experiencing depression and comorbid anxiety.